Digital intervention delivered via street medicine to increase HIV and substance use care among survivors of sexual trafficking

Project Summary
Sex trafficking is a unique form of sexual violence and a growing concern. Substance use, HIV, STI, and
psychological distress (e.g., PTSD, depression, anxiety) are common and interrelated morbidities among victims
of sex trafficking. Problematically, substance use treatment, HIV and STI treatment/prevention, and mental health
treatment are under-utilized by trafficking victims potentially because of stigma, lack of knowledge, lack of trust
in providers, and lack of access. Consistent with the goals of RFA-DA-25-018 Engaging Survivors of Sexual
Violence and Trafficking in HIV and Substance Use Disorder Services, the objective of this R34 application is to
develop and evaluate the CONNECT program for use in a sample of women with a history of sex trafficking to
evaluate its feasibility, acceptability, and preliminary efficacy. CONNECT will be delivered in collaboration with
the Street Medicine team, which provides health and social services directly to unhoused women in their own
environment; who are at high risk for sex trafficking. CONNECT will also be administered with the support of a
trained care navigator to provide 1:1 assistance in completing CONNECT and navigating referrals to substance
use, HIV/STI, and mental health care. Following ADAPT-ITT framework and informed by a Community-Based
Participatory Research approach, information from informant interviews (N = 9), focus groups (N = 30),
stakeholder interviews (N = 6), and the Community Advisory Board will be leveraged to adapt the intervention.
An open trial (N = 12) with a 2-month follow-up will be conducted to demonstrate program feasibility, acceptability,
satisfaction, and utility of CONNECT. A randomized pilot trial (N = 60) with a 2-month follow-up will be conducted
to examine whether women randomized to CONNECT, relative to control, show change in: treatment
engagement outcomes for substance use (e.g., MOUD initiation, therapy for alcohol use), HIV and STI
treatment/prevention services (e.g., uptake of PrEP, testing for STI), and/or mental health treatment (e.g.,
treatment for PTSD). Secondary outcomes of domains relating to motivation to seek treatment aligned with the
theory of planned behavior (i.e., attitudes, intentions, self-efficacy, subjective norms, and stigma will be explored.
Behavioral outcomes of changes in substance use outcomes (e.g., reduced substance use), HIV and STI risk
behaviors, and mental health outcomes (e.g., improvements in PTSD) will also be examined. Mediators (i.e.,
readiness to change) and moderators (i.e., trauma history) will be examined (exploratory). To prepare for Hybrid
Type II efficacy trial, exit interviews will be conducted with participants (N = 20), and practitioners (N = 9) to
describe contextual factors that might influence subsequent implementation. This research is expected to
produce a scalable strategy to promote treatment engagement for multiple interrelated harms among women
with experiences of sex trafficking, with the goal of promoting multiple domains of wellbeing.

Public health relevance
PROJECT NARRATIVE Public Health Relevance Sex trafficking is associated with elevated substance use, risk for HIV/STI, and psychological distress. Interventions are needed to screen individuals for sex trafficking and increase treatment engagement to address risk for substance use, HIV/STI risk, and psychological distress. Accordingly, the current R34 will develop the CONNECT program for use among women with a history of sex trafficking, to increase treatment engagement for substance use, HIV/STI treatment/prevention, and mental health among this high-risk group; thereby enhancing well-being by reducing comorbid health concerns.